1/3-Recurrence Markers, Cognitive Burden and Neurobiological Homeostasis in Late-life Depression (Rembrandt)

PROJECT SUMMARY
Repeated major depressive episodes are particularly problematic for older adults who have a more brittle
recovery than younger adults. Our data show that, despite antidepressant treatment, almost 60% of remitted
older adults experience recurrence within four years. Beyond simply relying on past history and reported
current stress, it is unclear what neurobiological factors are prospectively associated with recurrence risk,
when these factors trigger recurrence, and how they contribute to the high rates of cognitive impairment
observed in late-life depression (LLD). Using a model of network homeostasis, we posit that depressive
episodes are characterized by disrupted homeostasis in key neural networks involved in affect regulation and
cognitive function. Our preliminary data indicate that treatment non-remitters have residual functional network
alterations and high network instability (higher fluctuations in temporal signal-to-noise ratio). We hypothesize
that remitters with residual functional network alterations and greater instability remain at high risk of
recurrence with subsequent stress exposure. This disequilibrium contributes to subsyndromal symptoms
followed by full recurrence. These processes may also contribute to the higher rate of cognitive impairment and
decline observed in LLD. Our groups have reported elevated rates of cognitive decline in remitted LLD and an
association of recurrence with accelerated brain aging. We hypothesize that greater neural reactivity to stress
may accelerate brain aging and cognitive decline and that deficits/variability in performance on tasks
dependent on ECN may serve as markers of network alterations and signal increased recurrence risk. The
goals of this study are to A) identify neurobiological factors that predict recurrence risk, and B) examine how
cognitive performance changes are both influenced by these same neurobiological factors and also predict
recurrence risk. Our approach is to conduct a three-site, two-year longitudinal study of remitted LLD and
never-depressed elders. Every 8 months we will conduct laboratory assessments, including clinical, cognitive
and neuroimaging assessments and an in-scanner stress paradigm, along with burst ecological momentary
assessments (EMA) of mood variability, stress exposure, cognitive performance, and passive actigraphy. As
an exploratory goal, we will examine whether continuous ecological monitoring of mood and activity can
provide early detection of recurrence. A subgroup will be continuously monitored by EMA and actigraphy for
state shifts (persistent worsening) or variance shifts (increased variability) in symptom severity. When shifts in
mood symptoms are identified, they will engage in ad-hoc clinical and neuroimaging testing. Results from this
study may be translated in clinical practice through the future development of easy-to-use platforms (e.g. apps)
that signal to clinicians increased risk of impending recurrence, thus allowing for swift therapeutic intervention.

Public health relevance
PROJECT NARRATIVE Depression is a recurrent illness and even with successful antidepressant treatment, older adults with late-life depression are at high risk of recurrence. However, neurobiological processes that contribute to vulnerability to recurrence are poorly understood, limiting our ability to target mechanisms in prevention studies. The current study will elucidate neurobiological contributors to recurrence, examine the interrelationship between recurrence and cognitive decline, and provide data on the predictive utility of clinical monitoring in older adults.